J. NRSA Training Core

Contact PD/PI: IMPERATO-MCGINLEY, JULIANNE L NRSA-Training-001 (244)
J. TRAINING CORE (TL1)
PROJECT SUMMARY/ ABSTRACT
The fundamental goal of the Weill Cornell Clinical and Translational Science Center TL1 Training Core Program
is to equip predoctoral and early postdoctoral trainees from diverse disciplines with the skills necessary to pursue
transformative clinical and translational research before their career paths are established by offering distinct
educational tracks culminating in advanced degrees that allow trainees to make an immediate impact in the clinic
or in industry. The TL1 Training Program has trained highly successful predoctoral medical students, surgical
residents and early graduate students, nurses and fellows recruited from all partner institutions. The TL1 trainees
are fully integrated into CTSC activities and have access to all services provided by CTSC partners. Building on
our successful training program developed over the last 14 years, we will introduce new courses, technologies
and workshops geared towards team-based research, creativity, leadership, innovation, entrepreneurship,
informatics, and precision medicine. The TL1 program offers a panoply of didactic programs available to TL1
Scholars including an Advanced Certificate in Clinical/Translational (C/T) Investigation intended for trainees who
are interested in learning the fundamentals of Clinical and Translational Research; a Master’s Program in Clinical
and Translational Investigation, the foundation of which is a Mentored Research Capstone Project in C/T
research that is conducted in a team environment; an - MD/MS, program, a Summer Fellowship in C/T research;
and innovative seminars, workshops, and courses offered throughout the year. Other groundbreaking training
includes mentored research and externships/mini-sabbaticals with biopharmaceutical companies that will enrich
trainees’ exposure to various career options in clinical and translational research. The diverse, highly skilled TL1
faculty and mentors are expertly trained to offer support for trainees throughout the program in order to help
them pursue successful translational research careers. The CTSC has also established multiple collaborative
resources to recruit and retain underrepresented populations. The enhanced TL1 will leverage the trainees to
more rapidly advance in the field of Clinical and Translational Science. The planned duration of appointments is
two years and, the projected number of trainees is 10 including 5 predoctoral, 5 postdoctoral trainees.
Project Summary/Abstract Page 2570
Contact PD/PI: IMPERATO-MCGINLEY, JULIANNE L NRSA-Training-001 (244)
REFERENCES:
1. Weill Cornell Medicine. Education & Training | Clinical & Translational Science Center,
https://ctscweb.weill.cornell.edu/education-training (accessed June 22, 2021)
2. Advanced Certificate Program in Clinical & Translational Investigation | Clinical & Translational Science
Center, https://ctscweb.weill.cornell.edu/education-training/programs/advanced-certificate-program-clinical-
translational-investigation (accessed June 22, 2021)
3. Clinical Research Methodology Curriculum | Clinical & Translational Science Center,
https://ctscweb.weill.cornell.edu/education-training/programs/clinical-research-methodology-curriculum
(accessed June 22, 2021)
4. Cornell Cooperative Extension. Cornell Cooperative Extension | Serving communities in New York state
and NYC, https://cals.cornell.edu/cornell-cooperative-extension (accessed June 22, 2021)
5. Imperato-McGinley J, Guerrero L, Gautier T, et al. Steroid 5alpha-reductase deficiency in man: an inherited
form of male pseudohermaphroditism. Science 1974; 186: 1213–1215
6. Myeku N, Clelland CL, Emrani S, et al. Tau-driven 26S proteasome impairment and cognitive dysfunction
can be prevented early in disease by activating cAMP-PKA signaling. Nat Med 2016; 22: 46–53
7. Wipperman MF, Bhattarai SK, Vorkas CK, et al. Gastrointestinal microbiota composition predicts peripheral
inflammatory state during treatment of human tuberculosis. Nat Commun 2021; 12: 1141
8. Meyer HC, Odriozola P, Cohodes EM, et al. Ventral hippocampus interacts with prelimbic cortex during
inhibition of threat response via learned safety in both mice and humans. Proc Natl Acad Sci USA. Epub
ahead of print December 10, 2019. DOI: 10.1073/pnas.1910481116
9. Meyer HC, Gerhard DM, Amelio PA, et al. Pre-adolescent stress disrupts adult, but not adolescent, safety
learning. Behav Brain Res 2021; 400: 113005
10. Weill Cornell Medicine. Englander Institute for Precision Medicine, https://eipm.weill.cornell.edu/ (accessed
June 22, 2021)
11. Rennert H, Eng K, Zhang T, et al. Development and validation of a whole-exome sequencing test for
simultaneous detection of point mutations, indels and copy-number alterations for precision cancer care.
npj Genomic Med; 1. Epub ahead of print July 20, 2016. DOI: 10.1038/npjgenmed.2016.19
12. Weill Cornell Medicine, NewYork-Presbyterian Hospital and Illumina Collaborate on Scalable Clinical
Whole-Genome Sequencing Initiative | Newsroom | Weill Cornell Medicine,
https://news.weill.cornell.edu/news/2020/12/weill-cornell-medicine-newyork-presbyterian-hospital-and-
illumina-collaborate-on (accessed June 22, 2021)
13. Harris PA, Taylor R, Thielke R, et al. Research electronic data capture (REDCap)--a metadata-driven
methodology and workflow process for providing translational research informatics support. J Biomed
Inform 2009; 42: 377–381
14. NYC Health & Hospitals. Coler, https://www.nychealthandhospitals.org/coler/ (accessed June 22, 2021)
15. Overton J, Dickison M, Hootman K, Shukla A. Influences on Adolescent Food
Decisions. Obesity November, 2020 28(S2):249
16. Berk RA, Berg J, Mortimer R, et al. Measuring the effectiveness of faculty mentoring relationships. Acad
Med 2005; 80: 66–71
17. Gilmore-Bykovskyi A, Jackson JD, Wilkins CH. The Urgency of Justice in Research: Beyond COVID-19.
Trends Mol Med. Epub ahead of print November 17, 2020. DOI: 10.1016/j.molmed.2020.11.004
18. Weill Cornell Medicine. Tri-Institutional Minority Society | Graduate School of Medical Sciences,
https://gradschool.weill.cornell.edu/tri-institutional-minority-society (accessed June 22, 2021)
19. WCM Women In Medicine & Science | Office of Diversity and Inclusion,
https://diversity.weill.cornell.edu/diverse-communities/women-medicine-science (accessed June 22, 2021)
20. SPARC Jr | Office of Diversity and Inclusion, https://diversity.weill.cornell.edu/student-diversity/enrichment-
programs/sparc-jr (accessed June 22, 2021)
21. First Year of Diversity Faculty Development Mentoring Circles Program Completed | Weill Department of
Medicine, https://medicine.weill.cornell.edu/news/first-year-diversity-faculty-development-mentoring-circles-
program-completed (accessed June 22, 2021)
22. Black & Latino Men in Medicine Conference | Office of Diversity and Inclusion,
https://diversity.weill.cornell.edu/communities/black-latino-men-medicine-conference (accessed June 22,
2021)
23. Diversity Mentoring Cascade | Cornell Center for Health Equity,
https://centerforhealthequity.cornell.edu/education/diversity-center-of-excellence/diversity-mentoring-
cascade/ (accessed June 22, 2021)
References Cited Page 2571